Pragmatic trial of midodrine as a vasopressor-sparing agent in septic shock

PROJECT SUMMARY/ABSTRACT
The objective of this study is to conduct a pragmatic, randomized clinical trial to evaluate the effectiveness and
safety of oral midodrine in patients with sepsis associated hypotension. This patient-centered study approach is
seeking alternatives to minimize the burden of intensive care unit (ICU) stay in these patients. Sepsis is one of
the leading causes of death and disability worldwide. Cardiovascular compromise in sepsis manifests as
hypotension due to arterial vasodilation. Hypotension often persists despite initial fluid resuscitation, prompting
additional fluid boluses and subsequent administration of intravenous vasopressor agents. Although peripheral
intravenous access could be used to initiate vasopressor treatment, the need for close blood pressure monitoring
requires ICU admission and, for any but very short-term use, arterial and central venous catheter placement.
Both excess intravenous fluid and arterial and venous catheterization may expose the patients to risks,
unintended harms and discomfort. Moreover, a persistent need for intravenous vasopressor infusion prolongs
ICU stay with associated burdens and cost. Midodrine is an oral vasopressor agent originally approved for use
to treat orthostatic hypotension. Observational studies have suggested increasing off-label use of oral midodrine
as a vasopressor-sparing agent in various groups of critically ill patients. Randomized controlled trials showed
mixed results likely due to the heterogeneous general ICU patient population. Our preliminary data and the
existing evidence point to clear equipoise and the need for conducting the proposed pragmatic single-blinded
randomized clinical trial to evaluate both the safety and effectiveness of midodrine for sepsis associated
hypotension. Our hypothesis is that administering oral midodrine to patients with septic shock who have received
initial fluid resuscitation, appropriate antimicrobial treatment, and source control will decrease the duration of
intravenous vasopressor treatment. If efficacious, midodrine can facilitate less invasive sepsis treatment and
decrease the burdens and cost of ICU stay.

Public health relevance
PROJECT NARRATIVE Sepsis is among the leading causes of death in the hospital. The treatment of sepsis includes appropriate antibiotics, fluid administration and most often needs administration of intravenous medications to elevate blood pressure (vasopressors). Intravenous vasopressor infusion requires placement of invasive venous and arterial catheters associated with patient discomfort, complications and costs that include longer intensive care unit stay. Midodrine is an oral vasopressor agent that has been FDA approved to treat low blood pressure in certain specific conditions and has recently been used off label in many hospitalized patients to reduce the need and duration of intravenous vasopressors. However, the safety and efficacy of this practice has not been systematically evaluated, thus the critical need for the proposed clinical trial. If proven safe and effective, oral midodrine can become a very attractive alternative to intravenous vasopressors in patients with sepsis, mitigating associated burdens, risks, and costs.